Maintenance, germ-layer induction, and patterning of neuromesodermal progenitors

During the establishment of the vertebrate body, the head forms first and the rest of the body
grows progressively away from the head. A population of neuromesodermal progenitor cells (NMPs)
located at the posterior-most end of the embryo fuels this process of posterior growth. NMPs
maintain germ-layer plasticity after the end of gastrulation, and contribute to the growing spinal
cord, somites, and blood vessels. NMPs are critical cells required for the formation of the body,
yet due to their late temporal role in embryogenesis and the fact that they utilize many of the
same genes and signals that are essential for gastrulation, they have been extremely difficult to
study. My laboratory has developed methods using the zebrafish embryo to manipulate NMPs in vivo,
using a combination of cell transplantation and temporal genetic manipulations. These methods
allowed us to determine the existence of zebrafish NMPs and to define some of the basic molecular
properties that facilitate their germ-layer decision between mesoderm and ectoderm. This proposal
builds on our past studies and will examine the molecular control of NMP maintenance and
patterning. In Aim 1 we will use cell transplantation of new sox2 and sox3 mutant zebrafish lines
and heat-shock inducible sox2 and Wnt signaling transgenic lines to determine how Sox2 and Wnt
signaling collaborate to maintain NMPs through regulation of a new class of Wnt/βcat target genes.
In Aim 2, we will determine how the Bone Morphogenetic Protein (BMP) pathway acts as a morphogen to
pattern the mesodermal germ layer into distinct cell types. This aim will use new methods to
precisely regulate the intensity and duration of signaling pathway activation in individual
transplanted cells. The results of our study will help decipher some of the basic underpinnings of
vertebrate body formation, and will provide essential information regarding the use of stem cells
for regenerative medicine.

Public health relevance
Neuromesodermal progenitors are a newly discovered vertebrate embryonic cell-type that have the ability to generate a host of different tissues, including spinal cord, skeletal muscle, bone, blood vessels, and other essential components of the body. Understanding how these progenitors are maintained and patterned to form different tissues will inform our ability to manipulate stem cells for use in regenerative medicine.